CALLOSAL THICKNESS IN ADHD

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Corpus callosum morphology will be assessed in healthy controls and patients with Attention-Deficit/Hyperactivity Disorder (ADHD). The corpus callosum region will be delineated manually following a defined tracing protocol. Computational surfaced-based techniques to encode callosal thickness at high resolution will then be applied to compare groups.